Core B: Clinical Translational Core

The Clinical Translational Core B will: (1) enable intellectual and developmental disabilities (IDD)-related
clinical research to accelerate translational studies of the causes, associated clinical features, and new
interventions in IDD; (2) incorporate non-traditional approaches into IDD research, including pragmatic clinical
trials within learning healthcare systems and remote interventional studies and (3) enhance inclusion of IDD
populations into ongoing (non-IDD) research studies by providing investigative teams with the necessary tools
and trainings to support these populations. These efforts will facilitate inclusion of people with IDD into ongoing
clinical and translational research, especially in studies from which they have previously been excluded. The
Core’s services include (1) hands-on support to IDDRC research teams in the form of targeted consultations
that tailor “condition-agnostic” Vanderbilt resources such as the
Recruitment Innovation Center, which
implements recruitment and retention strategies for clinical trials, to the needs of IDD populations; (2)
maintenance and expansion of two research registries, one for autism spectrum disorder and one for Down
syndrome; (3) consultation on data pulls for electronic health records and genetic databanks; (4) various
methods to enable remote research, including online research portals and telehealth research approaches;
and (5) hands-on support to non-IDD research teams to enhance inclusion in studies, including modifying
Electronic Consent (eConsent) for IDD populations. These services are both responsive to investigator needs
as well as generative in adding value to IDD research locally and nationwide, via dissemination through
national networks. Overall, Core B’s services are focused on encouraging non-traditional researchers (e.g.
those not working on IDD) to become engaged in IDD research; enables research involving non-traditional
participants (e.g. people with IDD typically excluded from ongoing clinical research); and facilitates the use of
non-traditional approaches (e.g. pragmatic trials, remote research) into IDD research efforts. Thus, Core B’s
activities enable IDD research to be conducted optimally from study design to recruitment/consent, to
implementation, and also expands efforts to more appropriately represent those with IDD in non-IDD ongoing
research studies. Together these activities will accelerate IDD-related discoveries that will lead to high-impact
interventions and treatments, thus improving the lives of those with IDD and families.

Public health relevance
PUBLIC HEALTH RELEVANCE: As a group, intellectual and developmental disabilities, including Down syndrome and autism spectrum disorder, have dramatic effects on affected people’s and their caregiver’s lives. Unfortunately, there remains a lack of understanding about what causes these disabilities and, critically, how to treat them with targeted therapies. The Vanderbilt Kennedy Center’s Intellectual and Developmental Disabilities Research Center serves as the hub for Vanderbilt’s research efforts focusing on improving the lives of people with intellectual and developmental disabilities by understanding the causes of these disorders and developing and testing therapies tailored to each individual’s precise needs.